Combating melanoma resistance by targeting ABL1/2

SUMMARY
Despite treatment advances over the past decade, five-year survival rates for metastatic melanoma remain low
(23%). BRAF mutations occur in 50-75% of melanoma, and a combination of BRAF and MEK inhibitors (BRAFi,
MEKi) are effective therapies; however, acquired resistance rapidly develops for most patients. Research over
the past decade has identified mechanisms by which melanoma cells develop resistance to BRAF/MEK
inhibitors, but thus far, there are no FDA-approved regimens that reverse BRAFi/MEKi resistance and increase
the 5-year survival rate. Here, we demonstrate that the activities of the ABL family of non-receptor tyrosine
kinases are potentiated following BRAFi or BRAFi/MEKi resistance, and ABL1/2 drive resistance. Moreover,
targeting ABL1/2 with an FDA-approved anti-leukemia drug, nilotinib, dramatically reverses BRAFi/MEKi
(dabrafenib/trametinib) resistance, in vivo, inducing prolonged tumor regression. Based on these exciting
findings, the central hypothesis of our proposal is that ABL1/2 are key nodes that activate ERK-dependent or
-independent pathways to drive BRAFi/MEKi resistance; thus, targeting ABL1/2 may be effective for overcoming
resistance and ultimately extending survival for patients with treatment-refractory melanomas. Our long-term,
translational goal is to develop a novel regimen to improve the 5-year survival rate for patients with metastatic
melanoma. We propose a comprehensive hypothesis-driven experimental design and multi-disciplinary
approach. Aim 1 will define mechanisms by which ABL1/2 drive resistance. To achieve our objective,
biochemical, molecular biological and cell biological approaches using parental/resistant melanoma cell lines,
pharmacological inhibitors/RNAi, mass spectrometry, xenograft, GEM, PDX, and syngeneic in vivo approaches,
as well as human tissue collected from the clinical trial (Aim 3) will be used to test the hypothesis that ABL1/2
drive MAP3K activation of MEK/ERK/MYC (ERK-dependent resistance); induce ERBB2/ERBB3 activation of
PI3K/AKT (ERK-independent resistance); and alter immune cell infiltration. In Aim 2, conditioned medium from
parental/resistant cell lines, co-culture experiments using in vitro and in vivo models, and serum collected from
animals and patients will be used to test the prediction that the ABL1/2-driven secretome contributes to
BRAFi/MEKi resistance. Finally, Aim 3 is a multi-site, seamless Phase I/II clinical trial that tests the safety of
combining nilotinib with dabrafenib+trametinib (BRAFi/MEKi) for treatment-refractory patients. Additional
endpoints include identifying the recommended Phase II dose, initial efficacy (PFS) based on Phase II data,
PK/PD studies, and initial exploratory biomarker development. Results from these studies not only will increase
our understanding for how melanomas resist the effects of BRAFi/MEKi but also will lay the groundwork for a
large, multi-center, randomized clinical trial.

Public health relevance
PROJECT NARRATIVE Metastatic melanoma is one of the deadliest cancers, and although immunotherapy and targeted agents extend survival, some melanomas do not respond to the treatments or develop resistance; thus, the 5-year survival rate remains dismal. This proposal examines the mechanism by which ABL family proteins contribute to BRAF/MEK inhibitor resistance and includes a clinical trial to test the safety and initial efficacy of an ABL1/2 inhibitor in combination with BRAF/MEK inhibitors for treating refractory melanomas.